From cells to communities: The multi-scale impacts of bacteriophages in the gut microbiome

PROJECT SUMMARY/ABSTRACT
Bacteriophages (phages) are the most abundant but least understood constituents of microbial communities.
This is especially evident in the mammalian gastrointestinal tract, where a diverse community of up to 1012
phages are present per gram of stool. Though mounting evidence suggests the importance of phages in
human microbiomes, methods of data generation and analysis routinely used in microbiome science neglect
important aspects of phage biology. Furthermore, there is a lack of foundational knowledge and experimental
tools for understanding phages and the roles they play in microbiomes. This lack of understanding is especially
salient when the burgeoning antibiotic resistance crisis is considered: many important human pathogens are
becoming increasingly resistant to our antibiotic arsenal. While a growing number of clinicians and scientists
believe that “phage therapy” (the therapeutic application of phages to remove specific bacteria from host-
associated microbiomes) will be important in our recovery from the antibiotic resistance crisis, phage therapy is
inconsistently effective. This is largely due to an incomplete understanding of how phages impact their target
bacteria, their off-target effects on other microbiome members, and their interactions with the mammalian host.
Without such knowledge, important facets of phage-centric microbiome community dynamics will remain
obscure and hinder robust and reproducible phage therapy applications. The goal of the proposed research
program is to build a deep understanding of the roles that phages play in host-associated microbiomes and to
eventually exploit this understanding to inform phage-based therapeutic strategies. We will work towards this
goal using phage isolates, bacterial culture, bacterial genetics, gnotobiotic mice, and systems biology
approaches. Using these tools, the proposed research program will build on my previous work with
Bacteroides thetaiotaomicron-infecting phages and will focus on an isolate of the prominent crAss-like phage
family, DAC15. We will determine how phenotypic heterogeneity in B. thetaiotaomicron influences resistance to
DAC15, the specific interactions between DAC15 and B. thetaiotaomicron that lead to productive infection, and
how DAC15 influences microbiome-host interactions. We will additionally build a collection of phages that
infect other members of a model human gut microbiome to facilitate similar work with diverse bacteria and
phages. Together, this work will be a much-needed foundation to understand the roles and identities of gut-
resident phages, will build tools for sustained and powerful phage-centric study of the gut microbiome, and will
inform the development of robust and reproducible phage therapy.

Public health relevance
PROJECT NARRATIVE Shifts in the composition and function of human-resident microbial communities (microbiomes) are increasingly implicated as determinants of human health. The proposed research program will use in vitro and in vivo model systems to gain mechanistic insight into the ways in bacteriophages (phages) affect the composition and function of gastrointestinal microbiome. This work will provide a foundation for future basic and translational efforts to understand and exploit phage-bacteria-host interactions to mitigate disease.